RNA regulation in germline development and fertility

Reproductive success and health depend on precise coordination between germ cells and their surrounding support cells, yet the mechanisms governing these interactions remain poorly understood. Our research team explores genetic, molecular, and cellular interactions between germ cells and somatic (non-germline) cells of the gonad. We focus on the basic mechanisms regulating reproductive system formation and function. Key questions are: 1) what establishes the cells that produce eggs and sperm? and 2) what maintains distinct cell types found in ovaries versus testes, including both germ cells and their supporting somatic cells, all of which are required for reproductive success and health. Our goal in pursuing this research program is to define the developmental mechanisms that regulate gonad and gamete development to prevent infertility. Extending the function of reproductive organs is expected to mitigate or eliminate health risks that accompany premature ovarian failure, perimenopause, and menopause. From a developmental perspective, disorders of sexual development (DSDs) are common, and include gonadal dysgenesis, dysregulated puberty, and sterility. Although common, the basis of most DSDs is unknown or results from genetic or hormonal anomalies during reproductive development. We will leverage powerful genetic tools, cell imaging, and comprehensive genomic and molecular profiling to define the developmental mechanisms and identify new therapeutic targets for preventing infertility and reproductive disorders.

Public health relevance
Germ cells are essential for fertility. Our long-term goal is to understand the mechanisms that regulate specification and maintenance of the germline. The immediate goal of our research is to investigate the function and contribution of conserved genes to stem cell specification and sex-specific development of the germline, which has implications for understanding normal reproductive development, Disorders of Sexual Differentiation, and fertility, areas of biomedicine greatly in need of more research.